Translational Research that Adapts New Science FORMaltreatment prevention (TRANSFORM)

ABSTRACT: OVERALL CORE
Every year, millions of children in the United States suffer child abuse and neglect (USDHHS, 2022). Our
CAPSTONE Center for Multidisciplinary Research in Child Abuse and Neglect (P50) Project renewal goals are
to advance a national resource center for conducting innovative research, disseminating emerging discoveries,
and training investigators, clinicians, policy makers, and other professionals committed to preventing the
occurrence of, and understanding the sequelae of, child maltreatment. The TRANSFORM renewal
(Translational Research that Adapts New Science FOR Maltreatment Prevention) will continue to build on
current state-of-the-art research methodologies and clinical practices to foster the next generation of
professionals committed to addressing the deleterious and persistent personal and societal burden associated
with child abuse and neglect. TRANSFORM builds upon the strengths of Mt. Hope Family Center, University of
Rochester, and the University of Minnesota, including large longitudinal databases on child maltreatment.
Additionally, a Resource Core incorporating statistical and methodological expertise from Dr. Jungmeen Kim at
Virginia Tech will further strengthen TRANSFORM, extend our geographical reach, and expand our
partnerships. TRANSFORM will continue to influence the field by serving as a national flagship Center on the
etiology and sequelae of child abuse and neglect. We are grounded in the developmental psychopathology
framework and adhere to a life course perspective in our research. TRANSFORM emphasizes a
transdisciplinary approach, integrates contextual and cultural considerations as well as multigenerational
influences to advance science and inform practice and policy. In doing so, TRANSFORM will apply the most
advanced concepts and methods derived from child maltreatment research, and leverage numerous
longstanding relationships within the child welfare community to make its impact. To achieve its objectives,
TRANSFORM will utilize two Research Projects, a pilot study, and three mutually-informative and integrated
Cores: a Dissemination and Outreach Core, a Resource Core, and an Administrative Core. This ‘team science’
model brings together professionals with different backgrounds including: basic and applied scientists who
provide much of the theoretical grounding for project hypotheses, program developers who are the architects
of evidence-based programs, research methodologists who advise on the appropriate experimental designs for
testing the models, measurements for assessing key constructs, and analytical methods for evaluating results,
and child-serving professionals who will participate in dissemination activities. TRANSFORM will be led by Drs.
Sheree Toth and Dante Cicchetti, internationally-recognized leaders in the field of child maltreatment, whose
collaborative work spans over four decades and provides a solid foundation for continuing to conduct
groundbreaking longitudinal, intergenerational, and intervention research that will contribute to widespread
engagement across multiple child-serving systems.

Public health relevance
PROJECT NARRATIVE: OVERALL CORE To advance the field of child abuse and neglect, a diverse and transdisciplinary team comprised of researchers, staff, consultants, and National Advisory Board with leaders from the Universities of Rochester and Minnesota will partner with the NICHD to enhance and expand the TRANSFORM Center (Translational Research that Adapts New Science FOR Maltreatment Prevention). Building on current state-of-the-art research methodologies and clinical practices that address the personal and societal burden associated with child abuse and neglect, TRANSFORM will continue to leverage theoretically-grounded evidence-based research and interventions to optimize outcomes in children. A broad audience of investigators, child-serving professionals, parental, and governmental stakeholders will be the target audiences for community engagement, dissemination, and outreach activities.